Advanced Colonoscopy Training Developed Through Manikin Sensorization and Computational Optimization Modeling

Project Summary/Abstract
More than 19 million colonoscopies are performed in the US each year, with 60% of adults between 55-75
years having at least one within the last decade (1-3). These procedures provide physicians with minimally
invasive access to diagnose and treat diseases such as colon cancer. While routine, colonoscopies are the most
expensive screening test routinely performed on healthy Americans, with a mean cost of $2,125 (4). Furthering
the cost is the wide variation in successful completion rates that occur based on the physician skill– While the
acceptable physician success rate is only 90%, this modest target today is only achieved after physicians complete
hundreds of patient cases (5-7).
In light of this, the investigators have developed the Manikin Advanced Feedback Trainer (MAFT) to improve
patient health and reduce healthcare costs through efficient and effective colonoscopy training. Efficient learning
is produced using a high fidelity sensorized manikin trainer and a virtual “coach” that uses optimization-based
feedback developed through optimization modeling. MAFT is rigorously developed through 3 Aims below:
Specific Aim 1: Develop and validate an extensive colon geometry dataset and a refined
sensorization system for the MAFT. Colon geometry of 959 patient virtual colonoscopies from The Cancer
Imaging Archive (TCIA) will be computationally measured with a user-friendly automated organ geometry
centerline program. In addition, this aim will advance MAFT through the refinement of sensor processing.
Specific Aim 2: Develop, validate, and execute a 3D optimization model to solve for optimal
endoscope steering control. For each specific colon geometry there exists an optimal set of endoscope
steering controls to successfully insert an endoscope to reach the cecum in optimal time and with minimal
trauma. An Optimization model will be developed to solve for this optimum, and then this program will be
executed across the large colon dataset.
Specific Aim 3: Develop and experimentally assess virtual coach to provide personalized and
progressive learning for the Manikin Advanced Feedback Trainer. Hypothesis (H1): MAFT system of
interactive feedback provided by a virtual coach will improve a physician’s cecal intubation rate (CIR),
Adenoma Detection Rate (ADR) through improved visualizations, and reduce endoscope forces that can cause
colon damage. The virtual coach will be developed and validated through Human Study 1 and 2 that utilizes
both attending physicians and residents. In Human Study 3 MAFT will be implemented into the surgical
residency program at Hershey Medical Center in Years 4 and 5, and residents’ skills at performing colonoscopy
will be assessed based on the well-established metrics of CIR, ADR, and GAGES assessment to validate H1.

Public health relevance
Project Narrative The goal is to improve the procedure of colonoscopy by improving a physician’s skill of probe insertion measured by the cecal intubation rate (CIR), improving a physician’s visualization thoroughness measured by colonoscopy adenoma detection rate (ADR), and reducing endoscope forces that can cause colon damage. This is achieved through the development of a Manikin Advanced Feedback Trainer (MAFT) that uses a sensorized manikin and offers guided optimization-based feedback to efficiently advance skills. The approach proposed adds broad knowledge about diverse colon anatomy geometries, optimal endoscope control strategies, and successful manikin sensorization training techniques.